Training in Biomolecular and Tissue Engineering

DESCRIPTION (provided by applicant): The Center for Biomolecular and Tissue Engineering (CBTE) at Duke University proposes a post-doctoral training program in the application of bioengineering principles to the design, manipulation, and quantitative characterization of biomolecules, cells, and tissues. The primary applications of these principles are in several rapidly growing fields of biotechnology, including tissue engineering, biosensors, drug delivery, and genomics. This interdisciplinary research and training program in CBTE involves 26 faculty from 11 separate departments, with primary appointments in one of three academic departments of Duke University (Biomedical Engineering, Chemistry, Mechanical Engineering & Materials Science), one of three basic medical science departments the Duke University Medical Center (Biochemistry, Cell Biology, and Neurobiology), or one of three clinical departments of the Duke University Medical Center (Anesthesiology, Pathology, Medicine, Radiation Oncology, and Surgery). The CBTE is an established Center on campus and has undergone significant growth since its formation in 1993. Trainees will be Ph.D., M.D., or M.D./Ph.D. post-doctoral scientists. Eight post-doctoral slots are requested to support fellows pursuing full-time research for 2-3 years in biomolecular, cellular, or tissue engineering. Ph.D. post-doctoral trainees will have long term career interests in academic research, while M.D and M.D./Ph.D. candidates will have interests in careers in academic medicine. This program will be used to develop an integrated training structure that provides a unique, multidisciplinary experience for post-doctoral fellows. Trainees will be co-mentored by engineering and non-engineering faculty. An integral aspect of this training program will be the creation of a formal training plan for each individual trainee, based on a self-assessment of skills and career goals (the Individual Development Plan). Interdisciplinary training will be supplemented by formal coursework and intensive workshops in complementary areas, including statistical analysis, writing, and mandatory training in research ethics. Trainees will also have the opportunity to perform short-term research rotations in up to three laboratories before finalizing their choice of a mentor. We will also take advantage of several long-standing and successful initiatives at Duke University to enhance the recruitment of underrepresented minorities as part of this post-doctoral training program.